Career Enhancement Program

PROJECT SUMMARY/ABSTRACT: Career Enhancement Program
The goal of the Vanderbilt-Ingram Cancer Center (VICC) SPORE in Gastrointestinal (GI) Cancer Career
Enhancement Program (CEP) is to provide individuals with the mentorship and collaborative interactions
necessary for them to have successful and independent careers in translational GI cancer research. We have a
multi-faceted and multi-layered plan for selecting and mentoring exceptional physicians and scientists to advance
careers in GI cancer research and care. The goal is to provide CEP recipients with both an integrated, multi-
disciplinary environment and an individualized mentored research experience that facilitate the development of
outstanding research programs and successful academic careers.